Administrative Core

Project Summary
The overall objective of the Administration (Admin) Core efforts is to provide a robust and dynamic
infrastructure for the Center of Excellence for Encephalitic Alphavirus Therapeutics that enables
consistent and notable progress through the milestones. Led by the Program Director, Dr. Jonsson
(UTHSC, University of Tennessee Health Science Center), the Core will be the main interface between
the Scientific Advisory Committee (SAC), the Research Project PIs, and NIAID. To support the
achievement of the aims and milestones of the Center, Dr. Jonsson will be supported by Jayne McKinnie
(Admin Core Associate) to: (1) ensure coordination and dissemination of information across the research
projects, (2) coordinate results required for filing intellectual property, (3) publish results of disclosed leads
and provide novel resources to the scientific community, (4) coordinate input into the refinement of the
product development plan outlined in the Overall section with our University partners and SAC, (4) attract
commercial partners for future SBIR or similar proposal efforts, and (5) administratively support the Center
in collaboration with our regulatory consultants to prepare for our meetings with the FDA at the end of year
3 and at the start of year 5. Specific aims of the Admin Core will be to: Aim 1. Organize, manage, and
document Center communications and findings; Aim 2. Manage and ensure fiscal responsibility and
regulatory compliance; and Aim 3. Manage lead prioritization and documentation, the refinement of the
Product Development Plan and a path to Commercialization.